CORE A - ADMINISTRATIVE CORE

CORE A – ADMINISTRATION
ABSTRACT
The primary goals of Core A – Administration are to provide leadership, coordinated communication, logistical
support, and statistical support for Program members and collaborators to expedite the successful completion
of the Program’s scientific aims. The Lead of Core A is Dr. Reuben Harris and the Co-Lead is Dr. Douglas Yee.
The specific aims of the Core are to 1) provide strong and consistent leadership; 2) provide administrative
services including statistical support to Program scientists, collaborators, and Advisory Board members; and 3)
coordinate Program communications including meetings, workshops, and outreach efforts. The efficient
administration of this multi-institutional, multi-investigator Program is essential for its success and has proven to
be effective over the >10 years that our team has been working together successfully. Drs. Harris and Yee both
have experience managing multi-investigator, matrixed grants, and they meet monthly to coordinate Program
management. They have worked collaboratively for over a decade on the topic of this proposal with the award
of a co-PI V Foundation grant in 2012. They are supported by a full-time Program Coordinator, Dr. Dean Bacich,
who provides day-to-day administrative support and organizes meetings, workshops, and other communication
and outreach activities. The Executive Leadership Team, which consists of Project and Core Leads, meets
monthly to review the status of scientific progress and budgets. In-person Program Workshops, which include
Project and Core Leads, Co-Leads, Key Personnel, postdocs, graduate students, and collaborators, are held
twice each year, alternating between University of Texas Health San Antonio (fall) and University of California
San Diego (spring). The External Advisory Board, which consists of 5 expert scientists and 5 patient advocates,
joins the team in person at the fall workshop and provides feedback on overarching goals, scientific results, and
ways to overcome potential problems. A 4-person Internal Advisory Board comprised of administrative and
scientific leaders at UT Health San Antonio also meets annually with Program leadership with a focus on
institutional support and facilities as well as Program outreach and fostering community relationships. All
meetings are hybrid with in-person and Zoom options to ensure maximal accessibility and full participation by all
members.

Public health relevance
CORE A – ADMINISTRATION NARRATIVE Core A – Administration provides critical support for all administrative activities of the Program, including budgetary and fiscal operations, logistical assistance, and reporting activities. Core A strives to facilitate scientific progress toward the overall goal of blocking the evolution of APOBEC-driven tumor types. It does so by providing strong and consistent leadership; efficient administrative services including statistical support to Program scientists, collaborators, and External/Internal Advisory Board members; and clear Program communications across all sites, which includes meetings, workshops, and outreach efforts.